DementiaBank: An open access language database to understand the progression of dementia

Abstract
We propose the expansion and development of the open-access DementiaBank database of
multimedia interactions for the study of cognitive-communication impairments in aging and
Alzheimer’s disease and related dementias. This work will rely on advances in data collection,
transcription, analysis, sharing, and web delivery achieved in the context of the overall TalkBank
Project. We will deploy and extend the growing assets of TalkBank and DementiaBank to answer
critical questions regarding the diagnosis, classification, and longitudinal tracking of language in
dementia. The overall goal of this work is to support the development of cognitive-linguistic outcome
measures and treatments that will improve the evaluation and effectiveness of early diagnosis, and to
identify those at risk for dementia. To reach that goal, we must solidify methods for data analysis and
machine learning training, Collaborative Commentary, automatic speech recognition, and algorithm
evaluation benchmarks. We will also focus on the expansion of dissemination methods to ensure the
DementiaBank tools and resources are meeting the needs of researchers and clinicians.

Public health relevance
We will deploy and extend the growing assets of TalkBank, AphasiaBank and DementiaBank to answer critical questions regarding the diagnosis, classification, and longitudinal tracking of language in dementia. We will use and refine our new automatic speech recognition (ASR) pipeline to create high quality transcripts from people with dementia for lexical, discourse, grammatical, phonological, and fluency analysis. We will use this new dataset to refine the methods for detection and progression tracking of Alzheimer's disease and related dementias.